Investigating the Role of Hepatic Glucagon Receptor Signaling in Healthspan and Aging

Project Summary:
Obesity and type 2 diabetes mellitus accelerate aging shortening the duration of healthspan. Conversely,
chronic calorie restriction extends healthspan. Most research aimed at understanding the mechanism by which
calorie restriction slows aging has focused on insulin and downstream signaling cascades. Similarly, the
accelerated aging in type 2 diabetes is largely attributed to dysfunctional insulin signaling. Glucagon, a hormone
that counter-regulates insulin, is commonly affected by these same interventions.
We have shown that glucagon receptor deletion decreases median lifespan by 35% in normal weight mice.
Glucagon receptor deletion shortens lifespan to a greater degree in diet induced obese mice and prevents the
extension in lifespan resulting from calorie restriction. This proposes that the hyperglucagonemia in obesity may
be protective against obesity accelerated aging and that glucagon is essential for calorie restriction to extend
lifespan.
Although the role of glucagon receptor signaling in aging has not been heavily investigated, the rigor of this
work is supported by known effects of glucagon on downstream messengers that extend healthspan. Both
AMPK activity and cyclic AMP are established mediators that extend healthspan. Glucagon activates AMPK
and increases cAMP.
Highlighting the significance of this proposal, Glucagon receptor agonists are entering the market for the
treatment of diabetes and obesity. To understand the potential impact of these agonists, we propose to study
the role of glucagon receptor signaling in normal aging, the accelerated aging in obesity, and the slowed aging
resulting from calorie restriction.
We propose 2 aims that focus on genetic (Aim 1) and pharmacological (Aim 2) manipulation to increase
glucagon receptor signaling. We will combine these models with dietary models of obesity and calorie restriction
and with genetic models of normal glucagon receptor signaling and glucagon receptor knockout to better
understand the role of glucagon receptor signaling in normal aging, obesity accelerated aging, and the slowed
aging resulting from calorie restriction.
We have established that glucagon is integral in extending lifespan in calorie restriction and maintaining
lifespan in obesity. We appreciate that insulin plays a key role in aging, but also recognize that pharmacologically
targeting insulin signaling is limited because of the key role of insulin in glucose homeostasis. Conversely,
glucagon receptor agonists are safe. In turn, this research provides a unique opportunity to identify a new,
therapeutically viable target to extend healthspan and lifespan.

Public health relevance
Project Narrative: Elimination of glucagon receptor signaling shortens lifespan and healthspan in mice. Preliminary data presented in this proposal suggests that increasing glucagon signaling can improve metabolic and physical function in aging mice. Herein, we propose to extend these preliminary findings to investigate the potential to enhance glucagon signaling to extend healthspan and lifespan.